Mutational processes underlying tumor development in United States Veterans

Precision oncology aims to identify specific characteristics of a tumor, for example pathological or genomic
features, that allow selection of a treatment most likely to achieve success in a patient. While a large number of
single genomic alterations have been identified by large scale exome sequencing efforts, the National Cancer
Institute MATCH trial has revealed that targeting single pathologic exonic alterations achieve clinical benefit in
a minority of cancer patients. For example, lung cancer has the most molecularly directed targets; however,
work from multiple studies, including those conducted by the VA National Precision Oncology Program (NPOP)
has shown that therapeutic targets are identified in <30% of cases. Furthermore, therapeutic target rates are
lower in Veteran lung cancer compared to public data repositories like The Cancer Genome Atlas (TCGA).
Therefore, there is a critically urgent need to develop new tumor biomarkers for precision oncology.
One reason for the limited success of current precision oncology approaches is current clinical sequencing
tests focus mostly on point alterations (ie. BRAF, EGFR, BRCA1/2), which do not reflect the phenotypic
consequences of the mutational processes that initially caused the tumor. Mutational processes that
underlie human cancer leave mutational signatures in the genome that can be identified by whole
genome sequencing (WGS). Seminal work by the Sanger Institute has identified mutational patterns
indicative of defects in DNA replication and repair, mutagen exposures, and enzymatic modification of DNA.
Currently, 79 single base substitution, 11 doublet base substitution, and 18 insertion/deletion signatures have
been identified that reflect these mutational processes. In addition, patterns of copy number variants can
identify tumor genomes that have undergone doubling events, chromothripsis, kategsis, loss of heterozygosity,
and homologous recombination based DNA repair deficiency. The major published catalogs of tumor
mutational signatures include cancers predominantly from individuals of English descent from efforts in the
United Kingdom. Whether the same mutational signatures are at work in tumors from Veterans, and those
from diverse genetic ancestries, is currently unknown.
We hypothesize that mutational signatures will identify carcinogenic mechanisms resulting from
Veterans’ service-related environmental exposures, provide clinical utility in defining treatment for
Veteran cancer, and will inform further preventative measures to limit cancer-causing exposures. In
order to test this hypothesis, we propose two independent Specific Aims. In Specific Aim 1, we will perform
whole genome sequencing (WGS) on Veteran tumors and extract known and novel mutational signatures,
comparing the Veteran signatures to public data. In Specific Aim 2, we will determine the clinical utility of
mutational signatures. Our enterprise-wide team will leverage the resources of the National Precision Oncology
Program (Kelley), the Million Veterans Program (Pyarajan) and VA cancer genomics expertise
(Maxwell/Kratz/Neff/Pritchard) to perform and analyze WGS from existing tumor DNA specimens housed within
NPOP. We will determine whether mutational signatures are superior biomarkers in predicting response to
therapy (Fojo) by coupling with disease-specific experts in genitourinary (Garraway/Montgomery/Rettig),
gastrointestinal (Kratz) and lung (Herman/Kelley/Klein) cancers.
At a fundamental level, whether the mutational signatures identified in civilian tumors are found in tumors from
Veterans and whether novel signatures might develop due to war-time exposures is unknown. Identification of
novel mutational signatures may therefore inform preventative measures. Leveraging the diverse Veteran
population, our findings will also greatly expand the knowledge of mutational processes in non-White
individuals. Finally, we will define pathways for novel target development to treat Veterans with cancer and
determine whether mutational signatures should be included in the Precision Oncology care of Veterans.

Public health relevance
Mutational processes that underlie human cancer leave mutational signatures identifiable by whole genome sequencing. Precision Oncology aims to target these underlying mutational processes. Seminal work by the Sanger Institute has identified mutational patterns, including single and doublet base pair substitutions, indels, and copy number alterations, and structural variants, that are indicative of defects in DNA replication and repair, mutagen exposures, and enzymatic modification of DNA. These mutational signatures could be prognostic or predictive. Determining if these mutational signatures predict treatment response in Veterans could provide expanded therapeutic indications for larger numbers of Veterans. At a fundamental level, whether the mutational signatures identified in civilian tumors are found in tumors from United States Veterans and whether novel signatures might develop due to war-time exposures is unknown. Identification of these novel mutational signatures may reveal new therapeutic targets and inform preventative measures to reduce exposure risk.